Mentoring in Patient-Oriented Research on Substance Use Disorders

Project Summary/Abstract
The overarching goal of this K24 Award proposal is to enable Dr. R. Kathyn McHugh (PI/applicant) to expand
her mentorship of the next generation of investigators in patient-oriented research (POR) on substance use
disorders. Dr. McHugh is a clinician-scientist whose work focuses on the nature and treatment of substance
use disorders, with a focus on behavioral and affective risk and maintenance factors and behavioral therapy
development and testing. The proposed K24 award consists of integrated training and research plans that will
provide Dr. McHugh with both (1) increased time to dedicate to mentorship of current and new mentees, and
(2) expansion of her own program of POR. This expansion would both broaden the impact of the work of Dr.
McHugh’s lab and facilitate enhanced mentorship of junior investigators. Target areas for mentorship will
include expanding currently funded projects to provide additional opportunities for investigator training and
extending mentorship to new investigators and mentorship programs. Target areas for expansion of POR
include (1) extension of existing POR in substance use disorder treatment and epidemiology through
secondary data analyses, submission of competing renewals for 2 current R01s, submission of a K12
Institutional Training Award, and grant submissions with new collaborators; and, (2) development of new
content expertise in medication treatment research in SUDs across the translational research continuum in
collaboration with experts in medication for SUDs at the preclinical (Dr. William Carlezon), human behavioral
(Dr. Scott Lukas) and clinical trial level (Dr. Roger Weiss). Mentees would be included in all elements of this
work as collaborators, co-authors, and co-investigators. McLean Hospital and Harvard Medical School provide
an ideal environment for the attainment of these objectives, including clinical units supportive of POR,
seminars and courses in designating training areas, and a highly active Clinical and Translational Science
Center, with a wide array of resources for career development and training. This K24 Award would provide Dr.
McHugh with the protected time to expand her mentorship in POR and to add new skills in medication trials for
substance use disorders designed to complement her prior expertise and to provide an impactful extension of
both her own POR and that of her mentees. These expansions of mentorship capacity and breadth of POR will
advance the ultimate goal of reducing the public health burden of substance use disorders.

Public health relevance
Project Narrative Mitigating the large and growing negative impacts of substance use disorders in the US and globally requires a substantial and diverse workforce of patient-oriented researchers focused on improving prevention and treatment. The goals of the proposed K24 Award are to enable R. Kathryn McHugh, PhD to (1) provide mentorship to junior investigators in patient-oriented research, (2) to expand her patient-oriented research in substance use disorder treatment, and (3) to develop new content and methodological expertise in medication trials for substance use disorders. This award would facilitate both expansion of the breadth of Dr. McHugh’s patient-oriented research and extension of her mentorship of the next generation of investigators committed to POR toward the ultimate goal of reducing the suffering caused by substance use disorders.